GROWTH HORMONE SECRETION IN MOTHERS OF GROWTH HORMONE DEFICIENT CHILDREN

This study is designed to compare integrated inprovocative growth hormone testing of mothers of affected children compared to mothers of normal children. In addition, studies of the X chromosome of the effected children (male) and their mothers will be performed to see if deletions are present which might further confirm an x linkage in the regulation of growth hormone production.